Addressing Body Image in Weight Management: An Overlooked Risk Factor for Poor Treatment Outcome Among Women

Project Summary
This Patient-Oriented Career Development Award (K23) is designed to promote the development of Dr. KayLoni
Olson as an independent, clinical research scientist focused on developing interventions to address factors that
contribute to individual variability and poor outcomes in behavioral weight management. Overweight and obesity
remain a major threat to public health and contribute significantly to health care costs in the United States.
Standard behavioral weight management (SBT) facilitates clinically significant weight loss for many individuals
but there is variability in treatment outcome. High weight and shape concern (WSC) is associated with less
weight loss among women in behavioral weight management. One potential explanation for this relationship is
that individuals with High WSC have more frequent negative thoughts about weight/shape which lead to
overeating episodes. We therefore propose to use the Obesity-Related Behavioral Intervention Trials guidelines
to refine an empirically-supported WSC treatment (the Body Project: BP) to increase suitability for adult women
with overweight or obesity and enhance treatment effects. The protocol will be iteratively refined using
exploratory sequential mixed methodology to more powerfully target WSC among women with overweight or
obesity and to ensure acceptability to the target sample (Aim 1). The revised protocol will be tested in a
randomized pilot trial to evaluate effects when combined with SBT (Aim 2). For the pilot trial, 60 women with
overweight or obesity who report High WSC and want to lose weight will be recruited. They will be randomized
to either a four-week WSC intervention (modified-BP) or a four-week, education-only control condition. All
participants will then receive 24-week SBT. WSC and body weight will be assessed at baseline, 4 weeks, and
after 24 weeks of weight loss. EMA will be utilized to evaluate treatment effects on negative weight/shape-related
thoughts and overeating episodes throughout treatment. To conduct this project the applicant will complete a
rigorous, targeted training program to acquire key skills necessary for the success of the project and to prepare
the applicant for independence as an obesity researcher. Key areas for growth including 1) behavioral
intervention development, 2) obesity stigma as a contributor to WSC, 3) ecological momentary assessment, 4)
advanced quantitative methods to assess treatment outcomes, moderating and mediating factors, and 5)
professional development. This training will be conducted under the primary mentorship of Dr. Rena Wing, with
co-mentors Drs. Rani Elwy, Rebecca Puhl, Graham Thomas, Shira Dunsiger, and contributor Dr. Meghan Butryn.
The skills acquired map directly onto elements of the proposed project but also position the applicant to expand
her program of research in innovative directions. This mentorship team, in combination with the infrastructure
and resources available through The Miriam Hospital and the Weight Control and Diabetes Research Center,
represent the ideal environment to accomplish the applicant’s training goals, foster professional development
and establish the applicant’s autonomy as an independent clinical obesity researcher.

Public health relevance
Project Narrative The current project targets body image as a risk factor for poor weight loss outcomes. Using the Obesity- Related Behavioral Intervention Trials (ORBIT) model, an empirically-supported body image intervention developed for adolescent females will be refined to increase suitability, appropriateness, and enhance treatment effects for women with overweight or obesity who are attempting weight loss. Utilizing a systematic approach to addressing risk factors for poor treatment outcome is aligned with priorities for personalized obesity medicine.